Monkey Alcohol Tissue Research Resource (MATRR)

PROJECT SUMMARY
The “Monkey Alcohol Tissue Research Resource” (MATRR) is an MPI research resource grant awarded to
Oregon Health & Science University and Baylor University. Importantly, the MATRR provides an opportunity for
laboratories with specific expertise in organ pathology, neuroscience and genomics the ability to extend their
research to a primate model with similar genetics, developmental processes, endocrinology, immunology,
physiology and neuroanatomy to humans. Thus, the MATRR is unique to the alcohol research field in
promoting a translational resource for mechanistic studies of alcohol-induced pathologies. The MATRR has
been highly successful in providing the alcohol research community access to tissue and data generated from
cohorts of monkeys that have completed a standard protocol to study voluntary alcohol self-administration. The
MATRR bioinformatics has established reliable, robust categories of drinking that encompass low, binge,
heavy and very heavy chronic intake patterns. The necropsy procedure is fully refined and allows for the
highest quality harvesting of all organs and tissues in the body. The procedure results in a wide distribution of
ethanol intakes (g/kg), clinical chemistry, functional brain images, genomics and cognitive behavior through a
dedicated web resource. MATRR users are routinely contacted for custom tissue preparations in addition to
the frozen and fixed tissue banked in the MATRR until requested. All tissues are accompanied by data on
organismal and alcohol intake variables to aid in rapid publication of findings. The MATRR resource has
exceeded all expectations in terms of tissue generation, inventory control, tissue requests, tissue utilization,
data analytics, novel data generated, publications, newly funded projects and new research directions. In this
renewal, we propose to add more cohorts from currently funded and proposed studies, for example, infant
tissue from a fetal alcohol spectrum disorder (FASD) model and additional cohorts following shorter alcohol
drinking (6 months) to complement the longer term (12 months) and repeated abstinence protocols. The
inventory control is aided by a unique web-based interface that also serves to administratively evaluate and act
upon tissue requests. In total, we have 291 registered users and have shipped over 5,285 tissue samples from
6,315 tissue and data requests. With each accepted request, an MTA is filed, and timely progress reports are
automatically requested. In the past funding, the resource has been extremely successful in the number of
publications (31 in 48 months) from 14 different laboratories at 11 unique universities or institutes. There
remain great opportunities to further build and refine this resource. Our goal is to have the MATRR
bioinformatics integrate data across disciplines, organs and individuals to generate new knowledge of chronic
alcohol use disorders. There is also opportunity to study additional tissue (infant), variations in the protocol
(brain biopsies) and additional datasets (cognitive assessments).

Public health relevance
PROJECT NARRATIVE The Monkey Alcohol Tissue Research Resource is unique to the alcohol research field in promoting a translational resource for mechanistic and genetic studies of alcohol-induced pathologies in primates with known alcohol intake and clinical history. The fully interactive website and analytics toolset, together with the structural foundation to examine reproducibility and reliability of phenotypes, is designed to dynamically interact with external research domains to advance holistic data integration for alcohol research.